Neuroimaging Core

Summary (Neuroimaging core) The purpose of the Center for the Study of Aphasia Recovery (C-STAR) is to better understand how external factors (aphasia treatment and brain stimulation) and internal factors (neurophysiology and neuropsychology) influence aphasia recovery. The proposed work acquires brain imaging data at different time points after stroke using different imaging modalities. The mission of the neuroimaging core is to integrate data from each of the clinical sites to optimally support the objectives of each of the research projects. First, the neuroimaging core will receive neuroimaging and behavioral data from each clinical site and archive de-identified data. Second, the neuroimaging core will be responsible for processing these data using state-of-the-art-tools. Third, the neuroimaging core will support and refine the tools we have developed to allow each research team to analyze their data and address specific research aims. Finally, the core will provide tools that aid in visualization of results. The proposed work will allow the neuroimaging team to refine, validate, showcase and disseminate the tools required for each of the project aims.